Impact of Pregnancy Microbiomes on Maternal and Child Cardiovascular Health in a Racially and Ethnically Diverse Cohort

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading cause of death in U.S. women. Hypertensive disorders of
pregnancy greatly increase risk for developing CVD later in life for both mothers and children. Hypertensive
disorders of pregnancy affect 16% of pregnancies, and are more prevalent among pregnant people of color,
highlighting the need for a health-equitable approach to understanding etiology and prevention/treatment.
The human microbiome is a compelling target for etiologic investigations of hypertensive disorders of
pregnancy because, unlike the human genome, it can be modified. Cross-sectional studies, case-control
studies, and murine models suggest oral, gut, and vaginal microbes can cause cardiovascular diseases,
including hypertensive disorders in pregnancy, through their production metabolites. However, previous human
studies have not integrated and jointly assessed the oral, gut, and vaginal microbiomes in pregnancy; have not
concomitantly examined the role of microbe-dependent targeted and untargeted metabolites; have been limited
to a single time point in pregnancy; and have been in populations that lack racial and ethnic diversity.
To address these gaps, we will conduct an ancillary study to an ongoing NIH-funded cohort to investigate the
associations of maternal microbiomes and metabolomes with hypertensive disorders of pregnancy and
maternal child CVD risk factors. Key objectives are to: (1) characterize the distinct body-site specific
microbiomes (oral, gut, vaginal) and metabolomes of pregnant persons in a racially and ethnically diverse
population, and (2) determine the relative importance of different microbiome niches, microbiome features
within these niches, and critical windows for possible intervention to reduce hypertensive disorders of
pregnancy and future CVD risk for mothers and their offspring. In particular, we propose to perform whole
genome shotgun metagenomics, targeted quantification of short chain fatty acids, trimethylamine N-oxide, and
nitrite and nitrate, along with untargeted metabolomics for discovery. We will jointly investigate the
microbiomes and metabolomes measured during the 1st/2nd and 3rd trimesters in pregnancy.
Drs. Mueller (contact MPI) and Moore (MPI) will carry out this research with an outstanding group of
interdisciplinary co-investigators in the collaborative and eminent environments of the University of Colorado
Anschutz Medical Campus. Dr. Mueller and Moore’s co-investigators have complementary expertise in
statistics (Zhao), -omics analyses (Perng), computational biology and informatics (Olm), body composition and
cardiometabolic diseases (Tilves), and community-based dissemination (Rinehart). With the support of their
research team, Drs. Mueller and Moore are well positioned to complete the proposed activities. The findings
have great potential to: (a) identify early predictors of hypertensive disorders in pregnancy that can be targeted
for prevention, (b) reveal novel mechanisms of these hypertensive disorders, (c) offer new disease prevention
strategies and therapeutic possibilities, and (d) inform use of the microbiome-metabolome nexus for precision
nutrition/medicine.

Public health relevance
PROJECT NARRATIVE Our study aims to improve our understanding of how microbial communities and the small molecules they produce impact hypertensive disorders in pregnancy and the cardiovascular health of mothers and children after pregnancy. We will also examine the relative importance of different body-site specific microbial communities (intestinal, vaginal, oral) and timepoints during which they are assessed in pregnancy (e.g., 1st/2nd vs. 3rd), and how these microbial communitiees can be modified (e.g. by diet or other exposures), which may inform novel preventive and therapeutic strategies for maternal and child cardiovascular health.